Cancer Center Administration

ABSTRACT: ADMINISTRATION
The Office of Cancer Research Administration (OCRA) at the NCI-designated Sidney Kimmel Cancer Center
(SKCC) provides comprehensive programmatic direction and strategic support across the cancer research
continuum. Administration has developed a strong foundational platform to support the center’s research
infrastructure comprised of 165 members inclusive of four Research Programs, six CCSG-supported Shared
Resources, and a robust clinical trials office. Under the direction of Matthew Huesser, MBA, DBA, who reports
directly to the Center Director, a comprehensive Administration unit has been integrated across the consortium
and aligned with the strategic plan. OCRA is comprised of four groups directly reporting to Huesser: Research
Services, Business Operations, Communications, and Consortium Administration, totaling 20 FTEs, a growth
of eight (40%) over the project period. During that time, business operations were folded into the OCRA,
creating the necessary pathways to align both the research and clinical arms. Furthermore, the OCRA works
directly with centralized institutional offices including the Office of Research Administration (Thomas Jefferson
University’s grants office), the Jefferson Clinical Research Institute (clinical research business and contract
operations), Office of Institutional Advancement (philanthropy), Human Resources, and Marketing.
The activities of Administration are driven by the strategic plan and include ten major functions: 1) Facilitating
strategic planning, implementation, and evaluating processes; 2) Fostering the alignment of catchment area
needs with Research Program priorities; 3) Centralizing documentation and communication efforts related to
SKCC-organized operations, meetings, and retreats; 4) Providing CCSG application oversight including fiscal
management of funds, adherence to NCI guidelines,and CCSG metric reporting; 5) Directing space allocation
processes in order to promote research efficiencies and shared utilization of facilities; 6) Overseeing SKCC
faculty recruitment and retention efforts; 7) Disbursing and supervising developmental funds processes; 8)
Managing clinical research and shared resource operations; 9) Governing membership processes, consortium
relations, and collaborations with other institutions; and 10) Supporting cancer research career enhancement-
related initiatives and center-wide DEI efforts. Key accomplishments during the project period included the
development and implementation of the new SKCC strategic plan (IMPACT PHL), support of leadership during
the Director transition, enhancement of the cancer relevance process, development of mechanisms to enhance
the center’s NCI funding base, completion of a comprehensive SKCC Member refresh in 2021-2022,
development of the SMART system to convert outdated processes and implement a transformational digital
platform, and lastly, strengthening of the consortium partnership.